Columbia University and Northern Plains Partnership for the Superfund Research Program

Summary
Tribal lands are impacted by more than 15,000 hazardous waste sites and 7,000 abandoned mines that can
disrupt the redox chemistry of aquifers and release toxic metals. In collaboration with tribal communities from
North/South Dakota, we found that arsenic (As) and uranium (U) affect drinking water in private wells and rural
water systems in the Northern Plains. Our data also show that in the 1990s/early 2000s Native Americans from
the Northern Plains experienced urinary As and U levels 2.5 to 5 times higher than other US populations, likely
contributing to a high burden of cardiovascular disease. Knowledge is needed on current metal exposure levels,
sources (local and distal), health effects (concurrent, latent, joint), mechanistic pathways, and effective
remediation systems. To address these scientific and technology gaps, we have established the Columbia
University Northern Plains Superfund Research Program. This new partnership has five Projects and four Cores
and will use systems science, local knowledge, and innovative technology through the following aims: (1)
Develop household-level spatial and temporal models of groundwater metal concentrations integrating new
measures of water As, U, and redox parameters with USGS and IHS data. These models can identify safe water
vs. where mitigation interventions are needed. (2) Trace sources and cycling of metals in water and biological
specimens through stable isotope measurements (U, Se) to reveal redox state and inform on local and distal
sources of contamination, directly addressing our communities’ concern. (3) Determine latent and concurrent
cardiometabolic effects of As and U in humans (Strong Heart As/U Lifelong study, SHAUL), and in human-
relevant mouse models. These data will enhance the assessment of causality and the role of early life exposures.
(4) Integrate molecular mechanisms of As and U toxicity using multi-omics (epigenomics, metabolomics) in
longitudinal studies in humans (SHAUL) and mice. The cross-species comparison can identify robust signatures
and mechanisms to help generate intervention strategies. (5) Develop sustainable interventions using light-
based, point-of-use water remediation technology for As/U. This system will produce and recycle adsorption
media with photosynthetic bacteria and alert residents before treatment failure. The Community Engagement
Core will be centrally located in the Northern Plains, contributing to all research activities and local dissemination.
The Data Management and Analysis and Administrative Cores will optimize use of the complex data generated
while respecting tribal data sovereignty and promoting evidence-based policies and practices to address
hazardous toxic metals and contribute to disease prevention. We will train the next generation of scientists in
systems science, technology, Indigenous research ethics, and community outreach. The breadth, depth, and
innovation of our approaches, the community’s central role, the institutional support, and our experience working
together will lay the groundwork for interventions that address key concerns for water quality and human health
in communities in the Northern Plains and near abandoned mines and Superfund sites.

Public health relevance
Narrative Hazardous metals in drinking water, which are common contaminants near Superfund sites and abandoned uranium mines, play a role in the high burden of heart disease and diabetes affecting rural communities in the US Northern Plains, including tribal communities. The Columbia University Northern Plains Superfund Research Program (CUNP-SRP) will generate new knowledge to understand the underlying mechanisms and possible solutions to exposures to hazardous metal mixtures using systems science, local community knowledge, and novel remediation technology. CUNP-SRP partnership and activities will be facilitated by our integrated approaches, the central role of the communities, strong institutional support, and our team’s successful experience working together on translational science relevant for Superfund sites, which together will enable us to lay the groundwork for effective interventions to reduce potentially hazardous drinking water contamination.